Variable natural killer cell responses in the control of Epstein-Barr virus infection

Project summary
1 Epstein-Barr virus (EBV) infects approximately 95% of individuals, with most having an asymptomatic, latent
2 infection. However, EBV can drive immunopathological and malignant diseases in some, resulting in >1% of
3 global cancer deaths. The immune system is critical in determining the balance between asymptomatic and
4 pathogenic infection. Natural Killer (NK) cells play an important role: NK cells recognize and kill EBV-infected
5 cells, and NK cell deficiencies lead to severe EBV disease. NK cell functions are modulated by germline-encoded
6 NK cell receptors, which engage ligands expressed on infected cells. Among these receptors are the Killer cell
7 immunoglobulin-like receptors (KIR), which recognize Human Leukocyte Antigen (HLA) as ligands. Both KIR
8 and HLA are extremely polymorphic, and their ligation is allotype-specific, such that individuals have a unique
9 repertoire of HLA and KIR allotypes that determines their NK cell response to infection. Further, the specific
10 peptide presented by HLA can alter KIR ligation, including three EBV peptides known to alter KIR-HLA binding.
11 Intriguingly, genetic variants in KIR, HLA, and EBV are individually associated with EBV disease, and I have
12 observed EBV polymorphism in positions expected to alter peptide-specific binding between KIR and HLA.
13 While these genetic associations suggest HLA, KIR, and EBV genotypes determine functionally distinct NK cell
14 responses during EBV pathogenesis, the impact of KIR/HLA genetic variation in controlling EBV infection prior
15 to disease onset, and the interactions between host and viral genetic variation, remain uncharacterized. Further,
16 the immunological mechanisms behind KIR-mediated antiviral immunity to EBV are not functionally defined.
17 The proposed research will test the hypothesis that allotype-specific ligation between KIR and HLA-peptide
18 complexes determine NK cell responses across individuals and EBV strains, resulting in genotype-dependent
19 immune control of EBV infection. Aim 1 will identify the KIR, HLA, and EBV genotypes that are individually or
20 jointly associated with circulating EBV load, using samples from 20 diverse populations. These genetic
21 associations will be integrated with KIR-HLA functional data, such as ligation avidity and signaling strength, to
22 discern the role of NK cell education and antigen recognition in controlling EBV infection. Aim 2 will complement
23 the identified genetic associations by functionally testing the ability of pairs of KIR and HLA allotypes to direct
24 NK cell cytolytic functions towards EBV-infected cells. KIR and HLA allotypes that underlie NK cell recognition
25 of EBV-infected cells will be identified, as will the EBV peptides and polymorphisms that enable or disrupt NK
26 cell killing through KIR and HLA. Together, these aims will determine the role of HLA and KIR polymorphism in
27 the NK cell-mediated control of EBV infection, providing clarity on the immunological mechanisms driving
28 established associations between EBV disease and HLA, KIR, and EBV genotypes. The proposed research and
29 methodologies will also facilitate my training in human immunology and genetics research, providing the
30 background necessary to transition into a tenure-track role studying the genetics underlying DNA virus immunity.

Public health relevance
Project Narrative The killer cell immunoglobulin-like receptors (KIR) modulate Natural Killer cell immunity to infected cells through recognition of Human Leukocyte Antigen (HLA). KIR and HLA are among the most polymorphic human genes, and this polymorphism is associated with risk of Epstein-Barr virus diseases, including Hodgkin’s lymphoma, Nasopharyngeal carcinoma, and infectious mononucleosis. In this project, I will determine the KIR and HLA polymorphisms that are associated with immune control of Epstein-Barr virus infection by Natural Killer cells.